Shared Resources Core-1: Integrated Clinical, Tissue, and Biomarker Data Base Core (ICTBD Core)

ABSTRACT (Shared Resources-ICTBD Core)
The overall objective of the Integrated Clinical and Tissue Biorepository/Biomarker Data Base (ICTBD) Core is
to enhance and upgrade our current ICTBD Core which is integrated with our Clinical Resource Core. This will
be accomplished through a multi-dimensional translational research approach which leverages the
Partnership's research/outreach Cores, clinical networks, community partners, and academic partners
developed through the 1st U54 funding cycle (2009-2015). The Partnership uses Translational Research
according to the two translational blocks (T1- Basic/Biomedical Research and T2- Clinical/Implementation
Research). During the 2nd U54 Cycle (2015-2020), the Partnership proposes to utilize the ICTBD Core to both
enhance existing T1 activities, and facilitate the transfer of projects developed in 1st U54 cycle from T1 to T2.
We will accomplish this through the following: 1) continue building networks to enhance biospecimen/data
collection and facilitate translational research, 2) provide patient consent/engagement into biospecimen and
clinical research protocols, 3) facilitate a platform of bi-directional exchange, education/training, and
information dissemination between the Partnership's T1/T2 activities and the Community Cancer Outreach
Core, 4) provide administrative support for T1 to T2 transition such as IRB preparation, monitoring, and patient
recruitment to enhance underrepresented patient participation in clinical trials, and 5) work in partnership with
our community partners and community oncologists to continue to build and sustain a comprehensive
biospecimen repository with focus on breast, colon, and prostate cancers from African Americans and Latinos
for the purpose of identification of novel markers for assessing risk of cancer incidence and progression that
may be unique to ethnic groups and reduce cancer health disparities. These activities will dually enrich both
sides of the CDU/UCLA Partnership by bolstering CDU's institutional capacity for translational research with
UCLA-JCCC resources, and diversifying access for UCLA-JCCC to improve engagement of underrepresented
participants in research.